Administration

CANCER CENTER ADMINISTRATION – PROJECT SUMMARY/ABSTRACT
The Cancer Center Support Grant (CCSG) is administered by the Cold Spring Harbor Laboratory (CSHL) Cancer
Center under the direction of Denise Roberts, the Deputy Director for Administration, who reports directly to the
Cancer Center Director, David Tuveson. Roberts and Tuveson are assisted by an Administrative team dedicated
to the Cancer Center, comprised of Lindsey Baker (Associate Director of Research and Administration), Jaclyn
Jansen (Associate Director of Education and Administration), Sydney Gary (Associate Director of Operations
and Administration), Laura Lynn (Manager of Translational Research), and Jessica Peluso (Cancer Center
Coordinator). The Administrative team helps to support the planning and oversight of Cancer Center goals, the
three Research Programs, and the ten Shared Resources. The carry out this function by aiding Cancer Center
Leadership in developing and updating Cancer Center policies, gathering key data needed for decision-making,
managing the Cancer Center membership process, gathering information and feedback from the 43 Cancer
Center members, organizing and documenting Cancer Center meetings, and tracking Cancer Center member
funding (currently totaling $11.8 million in peer-reviewed, and $9.2 million in non-peer-reviewed projects). The
team also provides support to Cancer Center members by coordinating educational and professional
development opportunities, and by helping members identify areas of collaboration that could then lead to large,
multidisciplinary projects. Finally, the Administrative team helps to manage and oversee the CCSG, including
preparing progress reports, preparing the competing renewal, overseeing CCSG reporting requirements, and
overseeing the management of the Cancer Center Shared Resources. In order to carry out these administrative
activities, the Cancer Center Administrative team partners with staff in numerous departments of the CSHL
Institutional administration, including staff in the Office of Sponsored Programs, Human Resources, Finance and
Accounting, Procurement, Information Technology, and Research Compliance Departments. Altogether, the
support provided by the CSHL Cancer Center Administration helps ensure that the Cancer Center runs efficiently
and that members have access to the services they need to perform state-of-the art cancer research.

Public health relevance
ADMINISTRATION- PROJECT NARRATIVE Not required per PAR-20-043